Metabolism and Nutrition Training Program

PROJECT SUMMARY
This renewal application seeks continued support for the successful Metabolism and Nutrition Training
Program (MANTP). The fundamental rationale is to leverage the unique research and educational resources at
the University of Wisconsin-Madison (UW-Madison) to meet the need for the next generation of nutrition
scientists and realize the promise of personalized nutrition by recruiting and preparing qualified predoctoral and
postdoctoral trainees for biomedical science-related careers that impact the health of the Nation. The specific
objectives of the MANTP are to: 1) Create an exceptional training environment that engages and educates
predoctoral and postdoctoral trainees (MD and/or PhD) for 2- or 3-year appointments in collaborative, cross-
disciplinary research, centering on themes of Digestive Biology, Macro- and micro-nutrient Metabolism, Gut
Microbiome, Obesity and Disease, and Systems Biology. Our team of thirty-three well-funded trainers, from
various basic, applied, or clinical departments, will provide customized training emphasizing state-of-the-art,
integrative approaches to nutrition research. 2) Expand the trainees' knowledge base in multiple disciplines
through instruction and discourse between trainees and trainers from diverse backgrounds to bring a broad
array of perspectives and expertise to addressing nutrition-related human diseases. We propose a flexible
didactic plan that encompasses interdisciplinary breadth and integrative research methods. Trainees will also
receive comprehensive training on the rigor and reproducibility in all aspects of research, as well as in the
responsible conduct of research. 3) Cultivate physician- and dietitian-scientists for careers in nutrition-
related research. Our program will equip them with the skills necessary to conduct basic, applied, or
translational hypothesis-based nutrition research through individually designed didactic and mentoring
programs. 4) Enhance career competitiveness by providing a range of innovative professional development
opportunities, including grant writing, mock study section reviewing proposals, trainee-specific interactions with
visiting scientists from across the nation, collaborative retreats with the "Digestive Health Disease and
Nutrition" T32 at the University of Chicago, and a “mock interview” program for senior postdocs as they
transition to independent careers. These initiatives will increase trainees' exposure to translational research
and provide networking opportunities that benefit their research and career advancement. 5) Recruit and
retain underrepresented minority (URM) trainees for successful careers in nutrition-research. MANTP is
committed to institutional, departmental, and programmatic efforts to recruit URM trainees and create inclusive
climate that allow trainees of diverse backgrounds to thrive. With renewed support from the NIH, the MANTP
will continue to expand and refine its mission in producing expertly trained scientists with PhD, MD, RDN/PhD
and MD/PhD degrees who will make significant contributions as leaders in reducing the incidence of diet-
related diseases.

Public health relevance
PROJECT NARRATIVE While the significance of nutrition in preventing and treating many common chronic diseases is clear, the underlying biochemical and molecular mechanisms are often unknown, hindering the development of effective and sustainable interventions. In addition, individual differences in genetics, epigenetics, and gut microbiome can substantially vary the response to identical diets, highlighting the need to define the impacts and approaches of “precision nutrition” to improve health. This training program will produce PhD, MD, RDN/PhD, and MD/PhD scientists with the breadth of knowledge and experience in cross-disciplinary research needed to become leaders in elucidating mechanisms underlying variabilities in the responses to diet, allowing more tailored approaches to prevent or treat diet-related diseases.